Multispectral, high speed, super-resolution confocal microscopy system to support research in complex neurobiology

Project Summary The Salk Institute for Biological Studies is an independent, non-profit research institute in La Jolla, CA that focuses on fundamental basic science research. Shared resources and cores provide critical support for this research. Eleven technology cores serve the Institute, including the Waitt Advanced Biophotonics Core Facility, which is solely dedicated to technologies relating to multiscale light and electron microscopy imaging and analysis. This Core has a significant dependency on confocal microscopy. Confocal microscopy is a powerful research technology that is heavily utilized by NIMH-supported Salk scientists. In recent years, usage of core confocal microscope systems has increased significantly, and the ability to accommodate all requests has been possible only by operating all three existing confocal microscopes at near maximum capacity. However, the Zeiss 710 is over a decade old. This instrument has limited technical capabilities, decreasing reliability, and is near the end of its practical lifetime. The purpose of this grant application is to address a pressing and unmet need for a replacement instrument, by the acquisition of an Olympus FV3000RS TruSpectral Hybrid scanning confocal microscopy system. This new instrument would replace the aging Zeiss 710, which will be placed on the resale market, donated to a non-profit organization, or recycled. The FV300RS is a best-in-class instrument, ideally suited to the demanding imaging needs of Salk NIMH- supported researchers and others. It offers a vast improvement in imaging technology that meets the more advanced needs of the field. The system as configured has 7 excitation laser lines and unique holographic spectral separation technology that offers real-time 16-channel spectral separation with 2 nm resolution and very high light transmission. This improves signal to noise and offers true spectral un-mixing for challenging multispectral imaging needs. In addition, it has bi-modal scanning capabilities, allowing either super resolution precision laser scanning or very fast resonant laser scanning. It has 4 high sensitivity GaAsP photomultiplier detectors and is equipped with the new Olympus X-line objectives that offer unparalleled chromatic correction and image flatness without sacrificing high numerical aperture or large fields of view. For challenging 3D multispectral imaging of large tissue volumes that are needed for whole brain connectome and cell identity studies, this system has been configured with Olympus’s unique silicon immersion 40X objective. This is specifically designed for whole brain cleared tissue imaging. As configured, the FV3000RS TruSpectral Hybrid scanning confocal microscopy system offers flexible macro-to-micro scale, rapid and super-resolution multidimensional imaging of fixed and live samples and provides a complete imaging solution for the demanding needs of current and future neuroscience research. With the experience and expertise provided by the Waitt Advanced Biophotonics Core facility, this new instrument will be immediately put to a high level of use to facilitate scientific discovery.

Public health relevance
Project Narrative Multispectral high-resolution confocal microscopy is a powerful and fundamental quantitative imaging technology widely utilized by NIMH-funded researchers at the Salk Institute for Biological Studies. Funds are requested to replace a dated and increasingly unreliable Zeiss 710 confocal system with a state-of-the-art Olympus FV3000RS TruSpectral Hybrid Scanning Confocal system. This instrument will increase capacity and capabilities for high resolution, multidimensional confocal imaging across scales, from dendritic spines to large volumes of cleared brain tissue, which will significantly enhance NIMH-supported research.